THE ROLE OF VITAMIN B12-DEPENDENT METABOLIC PATHWAYS IN NEURAL CREST DEVELOPMENT

PROJECT SUMMARY/ABSTRACT
Neural crest cells (NCCs) comprise a multipotent population of cells that migrate throughout the vertebrate
embryo and differentiate into a wide variety of cell types and tissues such as the enteric, autonomic, and peripheral
nervous system; tissues of the adrenal gland, thyroid gland, heart, and eye; melanocytes of the skin; and
craniofacial bone and cartilage. Therefore, disruptions in NCC specification, migration, and/or differentiation can
affect many aspects of embryonic development leading to an array of debilitating congenital malformations
collectively called neurocristopathies. Thus, our long-term goal is to define the cellular and molecular mechanisms
governing NCC development leading to new therapeutic targets. In this proposal we aim to define the syndrome
combined methylmalonic acidemia and homocystinuria, cblC-type (cblC) – an inborn error of cobalamin (vitamin
B12) metabolism (IECM) – as also a neurocristopathy impacting mammalian development.
CblC is caused by mutation of the gene MMACHC, which encodes an enzyme essential for intracellular
trafficking and metabolism of cobalamin into its active coenzyme states. Without active cobalamin, dependent
metabolic pathways cannot function properly and consequently, severe neurodevelopmental defects, anemia,
retinopathy, and other congenital disorders result. However, the specific contributions of each metabolic
perturbation to the tissue-specific pathophysiology of cblC is largely unknown and there are no effective treatments
for affected infants and children.
In our preliminary studies, we discovered that Mmachc may play a role in neural crest development and
thereby redefine cblC as a neurocristopathy. Therefore, this proposal aims to use novel mouse models of IECM to
identify which specific cobalamin-dependent pathway, when disrupted, leads to neural crest developmental defects.
We will also investigate whether modulation of the maternal environment can improve the phenotypic presentation
of cblC defects in offspring. In total, these finding will shed much needed light on the pathophysiology of cblC and
likely inform patient treatment.

Public health relevance
PROJECT NARRATIVE Neural crest cells are stem cell-like cells that form a multitude of tissue types during fetal development, including the cells of the peripheral nervous system; pigment cells of the skin; and the craniofacial skeleton. Disruption of neural crest cell formation of these tissues causes a wide variety of congenital and pediatric disorders collectively called neurocristopathies, which include both developmental defects and cancers such as neuroblastoma. By studying the genetic and molecular pathways important for neural crest cell formation and differentiation, we may be able to develop therapies to treat or prevent neurocristopathies.